Neural circuits for decision making

PROJECT SUMMARY
Different people facing similar situations make different choices, and different choices result in
divergent life trajectories. Despite the pervasive impact on an individual’s life, the neural basis of
idiosyncratic decision-making remains largely unknown. Beginning to address this important topic,
we recently characterized idiosyncratic choice behavior quantitatively and identified a posterior
network comprised of the cingulate cortex, posterior parietal cortex, and striatum in which the
idiosyncratic choice biases are likely processed, transmitted, and integrated with other decision
variables. The posterior network imbuing idiosyncrasy might operate in parallel to the well-known
frontal network for rule- and value-based decision-making and the sensorimotor network for
stimulus-response association, all of which dynamically contribute to the final choice. However,
the detailed circuit mechanisms in the posterior network have yet to be discovered. We propose
a series of experiments in mice to elaborate information flows and processing in the posterior
network, utilizing well-established in-lab tools including behavior modeling, anterograde- and
retrograde-transsynaptic labeling, optogenetics, and two-photon imaging. Understanding the
neural circuits governing the moment-by-moment idiosyncratic history bias will shed light on the
neural origins of idiosyncratic decisions. Furthermore, life-interfering, maladaptive choice
behavior might be in part a manifestation of extremely deviated idiosyncratic bias, thus elaborating
the less known posterior network may bring new insights into pathological decision-making in
neurological conditions such as aging, dementia, and addiction.

Public health relevance
PROJECT NARRATIVE Idiosyncrasy is a fundamental trait in decision-making that impacts one’s life tremendously, and life-threating, maladaptive choice behavior in neurological/psychiatric disorders might in part stem from malfunctions of the neural circuits controlling idiosyncratic decisions. Recent scientific findings raise a compelling hypothesis that a posterior network in the brain may be central to the control of idiosyncratic choice biases. This project will test this hypothesis and elaborate information processing in the posterior network using advanced computational models and circuit interrogation tools in rodents, the gained knowledge from which will guide future research to identify the neural basis of pathological decision-making.